Nigrostriatal dopamine mechanisms of cognitive control

Project Summary/Abstract
Cognitive impairments, which affect memory, executive functioning, and timing, are experienced by the
majority of Parkinson’s disease patients at some point during their disease. For many patients, mild cognitive
impairments eventually devolve into Parkinson’s disease dementia. Despite the negative impact on quality of
life caused by these symptoms, there are currently no effective therapies to treat cognitive impairment in these
patients. Thus, there is an unmet need to develop new treatments for Parkinson’s disease-related cognitive
decline. This requires identifying the fundamental neurobiological mechanisms underlying cognitive dysfunction
in Parkinson’s disease.
Dopamine neuron degeneration in the nigrostriatal pathway is associated not only with the motor
symptoms of Parkinson’s disease, but also with cognitive symptoms. Parkinson’s disease patients have
reliably impaired performance on interval timing tasks and lesioning or manipulating dopamine neurons in
rodents also impairs performance on interval timing tasks. Furthermore, striatal neurons encode temporally
relevant information by ramping their activity across timed intervals. The overall goal of my proposed research
is to identify how nigrostriatal dopamine signals influence striatal microcircuitry during a cognitive task. My
overall hypothesis is that striatal temporal encoding depends on dopamine.
I will test this overall hypothesis with two distinct experiments. First, I will test the hypothesis that task-
modulated striatal dopamine activity predicts temporal encoding by striatal projection neurons during an
interval timing task. I will test this by recording local dopamine dynamics with striatal dLight and fiber
photometry while simultaneously recording striatal neuronal ensembles. Second, I will test the hypothesis that
dopamine neurons control striatal time-related ramping activity. I will optogenetically silence or stimulate
dopamine neurons at key behavioral events during the task while recording striatal neuronal ensemble activity.
Together, the proposed experiments will contribute to a model establishing how nigrostriatal dopamine
neurons regulate striatal cognitive processing. This knowledge will inform development of novel therapies for
cognitive impairments in Parkinson’s disease by identifying where and how to target treatments. This is highly
relevant for Parkinson’s disease and other dopamine-linked disorders, as this work will reveal foundational
basic science mechanisms of dopamine. Completion of the proposed work will not only expand my technical
and research skillset, but also enhance my professional development skills. Therefore, this award will advance
me towards my career goal of running an independent laboratory at a competitive research institution, focused
on dopamine and basal ganglia circuitry mechanisms of cognitively-guided action.

Public health relevance
Project Narrative Cognitive symptoms, ranging from mild cognitive impairment to dementia, affect the majority of Parkinson’s disease patients at some point during their disease, yet there are no effective treatments to address these symptoms. The goal of this proposed work is to determine how dopamine signaling affects striatal microcircuitry during cognition, laying the foundation to develop targeted therapies for Parkinson’s disease and other dopamine-related disorders. The scientific and professional development training I will receive during completion of this research will prepare me for my career goal of running my own laboratory at a competitive research institution.